Mechanisms of Dynamic Neural Coupling during Face-to-Face Expressions of Emotion

PROJECT SUMMARY
Little is known about the neural mechanisms that regulate natural dynamic cues during human social and
emotional interactions, although these mechanisms are impaired in many psychiatric and neurological disorders.
Although it is widely understood that social signals such as facial expressions carry salient, but implicit, emotional
and social cues, these “real-time” pathways have not been investigated with dual-brain neuroimaging techniques.
This unmet need is largely due to technological limitations that prevent neuroimaging of two or more individuals
during natural interactive situations. We overcome this technical “roadblock” with recent advances in an
emerging human brain imaging technology, functional near-infrared spectroscopy (fNIRS). This non-invasive
technique detects active neural tissue based on hemodynamic signals measured by variations in the absorption
spectra associated with oxyhemoglobin and de-oxyhemoglobin. Because detectors and emitters are surface
mounted on the head, absent a high magnetic field, they are relatively insensitive to head movement and thus
successfully applied to dyadic experiments. The focus of this proposal is to gain a comprehensive understanding
of the mechanisms that underlie dynamic cross-brain neural coupling during real interpersonal interactions.
Cross-brain neural coupling is defined as the correlation between the temporal patterns of the signals of two
brains. It has been proposed that these matched patterns represent shared neural processes including dynamic
exchanges of information. However, the basic assumptions of shared information and temporal resonance
patterns between specific brain-to-brain regions has not been tested. We pioneer tests of these hypothesis using
eye-to-eye contact as a metric of shared information and predict that dynamic neural coupling between the two
brains will increase with increasing numbers of eye-to-eye contact events. Mimicry of facial expressions is also
a metric of emotional contagion as well as shared information between brains. We further test the hypothesis
that neural coupling will increase with the level of mimicry also by virtue of the shared information Confirmation
of the hypothesis that neural coupling represents shared information between the two brains would provide a
singular advance for understanding mechanisms for dynamic interactions. Both approaches include variations
of emotive expressions to test the additional hypothesis that content as well as shared information might
influence dynamic coupling mechanisms. Findings from these studies are expected to open a new direction for
the study of live and dynamic interactions between individuals, and provide foundational components to a general
framework for models of face-to-face interactions. A long-term goal is to understand the neural underpinnings of
affective disorders as they present in clinically-relevant and real-world situations.

Public health relevance
Project Narrative How do two brains interact? We pioneer a novel neuroimaging technology, near infrared spectroscopy, to investigate basic mechanisms of neural coupling between two dynamically interacting individuals. Using these new methods we test the fundamental hypothesis that neural coupling (temporal synchrony between two brains) represents shared information across the two brains.